Administration and Management Core

All Collaborative Center’s activities will be managed, coordinated, and supervised through the Administrative
Core under the direction of the PI, Professor Christian Happi, who possesses many years of experience in
research and project management. The primary task of the Administrative Core is to facilitate accomplishment
of the stated goals of the Collaborative center to (1) Utilize Microbial Metagenomics for Viral Pathogen
Characterization; (2) develop field Diagnostics for Pathogen Surveillance; (3) Use Clinical, Genomic, and
Immunological Data for Studying Viral and Host Biology; and (4) Establish a comprehensive Educational Core
for training, capacity building, and technology transfer. In addition to supporting the above stated projects and
cores, the administrative core will leverage its network with academic, private sector, and public sector
institutions to provide career development and enrichment opportunities for academic trainees and early-career
scientists in the collaborative network, including . Each project has a particular emphasis area based on the
expertise of the investigators, providing a particular capacity (platform) that is available to the group as a
whole. The functional and thematic integration of these projects and cores allows quick transfer of knowledge,
technology, and resources within the collaborative center. Thus, steering effort and resources toward findings
showing the greatest promise and need.
The Administrative Core will build upon well-established collaborations between the institutions stated in this
proposal to: (1). Evaluate research and development progress and assist to facilitate collaborations, problem
solving, and creative ideas; (2) Facilitate communications within the Center, through the steering committee
meetings, teleconferences, regular communication; (3) Establish and coordinate the activities of the Scientific
Advisory Committee (SAC), whose role is to provide overall guidance to the Center; (3) Coordinate the
presentation and publication of data, resource and model sharing; (4) Organize and chair the annual
consortium meeting activities. (5) Identify problems and propose solutions through the steering committee and
engagement of the H3Africa consortium; (6) Provide semi-annual progress reports in a format to be defined by
the H3Africa Consortium after award; (7) Manage the Intellectual Property resources of the Collaborative
center and work with all stakeholders to facilitate the commercial development of relevant discoveries. In short,
this core will create and maintain systems to ensure excellent performance of the proposal’s stated aims,
efficient communication between partner institutions, and data dissemination to the broader H3Africa Network.